Translating Pathomechanisms into Treatment for Spinal Muscular Atrophies

PROJECT SUMMARY
Spinal muscular atrophies (SMAs) are monogenetic motor neuron (MN) diseases that cause debilitating muscle
weakness and often early mortality. Our research program focuses on advancing therapeutics for two forms of
SMA: proximal SMA caused by recessive, loss-of-function mutations of the survival motor neuron 1 gene (SMN1)
and distal SMA (dSMA) caused by dominant mutations of the transient receptor potential vanilloid 4 gene
(TRPV4). This administrative supplement to my R35 grant funded by the NINDS Landis Mentorship Award will
provide funds to augment the mentorship and training of four graduate students at Johns Hopkins University
School of Medicine with the long-term goal of fostering their future careers in biomedicine working to advance
treatment for neurodegenerative diseases. Each student will pursue a graduate thesis project that is within the
scope of research proposed in the parent R35 grant: Stephen Brown and Maddie Dent will focus on proximal
SMA and Anna Bagnell and Jonathan Alevy will focus on distal SMA. They will leverage unique resources and
state-of-the-art technologies to define factors limiting efficacy of current SMA therapeutics, characterize cellular
and molecular mechanisms driving SMA pathology, and identify and validate novel therapeutic strategies. In
order to foster their training, the first aim of the supplement is to provide regular one-on-one meetings for scientific
discussion including review of relevant literature, hypothesis generation, experimental design, and data
interpretation. The second aim to foster their training by enabling them to utilize cutting-edge experimental
techniques to pursue their scientific hypotheses. The third aim is to support travel of students to scientific
meetings for presentations and networking and the fourth aim is to create a rich community of trainees for “peer”
mentoring.

Public health relevance
PROJECT NARRATIVE Spinal muscular atrophies cause early onset, severe muscle weakness. Although new gene-targeting therapeutics are a breakthrough, efficacy in patients remains highly variable. This administrative supplement provided by the Landis mentorship award will support the training and mentorship of four graduate students who will define factors limiting current treatments, characterize molecular and cellular mechanisms of disease, and identify novel therapeutic strategies in order to improve quality of life for individuals with SMAs and related neuromuscular disorders.